Leveraging Electronic Health Data to Assess the Burden of Diabetes among Young Adults

Project Summary
Accurate, local information about population health and health related behaviors derived from electronic health
records may support the development of effective public health programs and policies. Ideally, public health
decision-makers would have up to date, comprehensive, representative information about the population they
serve. Unfortunately, commonly used data sources for community assessment fall short of this. Recent
advances in the adoption of electronic health records make it possible for public health to potentially access
more timely and accurate data. However, it remains unclear whether newer sources of data will enable
improved assessment of population health. In this project, a multidisciplinary team at Indiana University, the
Regenstrief Institute, and the Marion County Public Health Department will use integrated, representative
electronic health data to generate estimates of Type 1 and Type 2 diabetes by diabetes type, age, sex,
race/ethnicity and geographic area at state and county levels. These estimates will be evaluated for reliability
and validity. The estimates will further be shared with local and state public health officials for use in
addressing diabetes burden in the region.

Public health relevance
Project Narrative This research is necessary to advance methods for using comprehensive healthcare data to estimate chronic disease burden, assessing the reliability and validity of those methods, and comparing to traditional systems. Furthermore, this project will generate and evaluate diabetes incidence and prevalence and will share those estimates via a unique dashboard with public health authorities for the purposes of disease surveillance and prevention.